NPETE's Community College Consortium for Health and Safety Training

The National Partnership for Environmental Technology Education, ME, in partnership
with the Hazardous Materials Training and Research Institute, IA, submits this proposal on
behalf of the Community College Consortium for Health and Safety Training (CCCHST) to
provide memorable, cost-effective training for hazardous materials and waste workers engaged
in waste treatment, storage and disposal, hazardous waste generation, clean up and remedial
action, emergency response and hazardous materials transportation. CCCHST membership
consists of community and tribal colleges partnered with business and industry, universities,
and community-based organizations offering a consistent and quality response to the national
training need for hazardous waste workers and emergency response personnel.
The goal of CCCHST is to make NIEHS-approved worker training nationally available
through over 100 CCCHST organizations, whose instructors are prepared through a Train-the-
Trainer model program, offering hazardous materials instruction in nearly all states of the
nation. CCCHST instructors, prepared and supported by PETE and HMTRI, will annually train
a minimum 50,000 students, workers, and supervisors to protect themselves and their
communities from exposure to hazardous materials encountered during hazardous waste site
cleanup, Brownfields redevelopment, transportation of hazardous materials, and response to
spills and releases of hazardous materials, offering a minimum 3,000 courses each year. PETE
has two additional missions beyond this its core Train-the-Trainer model program.
(1) Military Haz Mat Worker Training. PETE will offer a direct worker training program
for Total Military Family (TMF) personnel, including veterans, military personnel and their
families transitioning to the public sector. Annually, 200 TMF members from Fort Riley (KS),
Fort Sill (OK), Fort Carson (CO), the Norfolk Naval Station (VA), and future expansion to the
Portsmouth Naval Shipyard (ME) and to West coast bases, will participate in one-week training
programs, leading to the HazWoper card and a variety of OSHA certifications based on need.
(2) PETE’s Disaster Preparedness Instructor Institute will annually prepare 20
CCCHST and partner trainers, including those from other NIEHS-awardees, who serve a wide
variety of students and responders. These trainers will return to their communities to annually
prepare an additional 1,500 responders in the Gulf, U.S. Territories, Tribal Nations, programs
serving CERT and Americorps students, and responders throughout the U.S.

Public health relevance
The goal of the Community College Consortium for Health and Safety Training (CCCHST) is to help the nation be better prepared to prevent and to respond to hazardous materials incidents through the training of instructors serving workers from business and industry; students from community and tribal colleges and technical schools, including first responders; transitioning military; and members of community-based and faith-based organizations in targeted communities. CCCHST will make NIEHS-approved training nationally available through over 100 CCCHST organizational members, prepared through a Train-the-Trainer model program, to offer hazardous materials and disaster preparedness instruction in nearly all states of the nation. Over 250,000 workers, students, and citizens, prepared by CCCHST instructors over a five-year period, will understand how to protect themselves and their communities when working with hazardous chemicals and hazardous situations.